Mechanisms of Herpetic Keratitis

DESCRIPTION (provided by applicant): Keratitis caused by herpes simplex virus (HSV) infection remains a troublesome ocular disease that can result in blindness. Effective vaccines against HSV that can either prevent or modify the severity of disease expression neither exist nor are on the horizon. About 20% of keratitis cases result in chronic inflammatory reactions in the stroma. These stromal keratitis (SK) lesions are usually managed by prolonged treatment regimens that are often unsatisfactory. Improved treatment approaches are required. These need to inhibit steps in the pathogenesis of SK that are responsible for tissue damage and to stimulate the activity, or provide surrogates, of host components responsible for healing and repair of the cornea. Identifying events in SK pathogenesis that are accessible for therapy can be accomplished most effectively using animal models of the human disease, all of which unfortunately have their shortfalls. We use the tractable primary ocular infection model in mice where the pathogenesis of lesion expression has many similarities to the human disease. From past studies, it appears that the most accessible steps for therapeutic management in the pathogenesis of SK are to: a) prevent events that initiate the influx of inflammatory cells to the stroma, b) counteract the development and extent of corneal neovascularization (CV) that both facilitates inflammatory cell entrance and also contributes to visual impairment and c) remove and/or blunt the function and products of inflammatory cell types responsible for causing tissue damage in the stroma, and expand events that are counter-inflammatory and promote resolution. Our proposed research is to understand at a fundamental level how the essential step of CV is triggered by HSV infection and can be controlled by appropriate forms of therapy. These studies will focus on the role that the cytokine IL-17A plays in the stimulation of new blood vessel formation and on approaches that can be used to inhibit the angiogenic effects of IL-17A. We shall also determine how the CV responses to the major angiogenic factor VEGF are regulated by events that include vessel stabilizing ligand/receptor interactions and micro RNA expression in VEGF responding cells. These observations are expected to result in the design of new therapies that control the extent of CV. Additional studies are designed to further define the role of neutrophils and proinflammatory T cells in orchestrating SK and the use of therapies that counteract their activities. These therapies will include derivatives of omega-3 polyunsaturated fatty acids such as resolvins and protectins which are both anti-inflammatory and promote tissue repair. We shall also use drugs that activate aryl hydrocarbon receptors expressed by activated T cells, which should inhibit the inflammatory activity of such cells as well as expand the representation of regulatory T cells. The final Aim will be to use drug combinations that target different steps in SK pathogenesis which are expected to have improved efficacy compared to single therapies to control disease severity and mediate tissue healing.

Public health relevance
PUBLIC HEALTH RELEVANCE: Stromal keratitis resulting from herpes simplex virus infection remains the most common infectious cause of blindness in the USA. There is a need to develop new approaches for control and treatment. This application, using an animal model system, will identify steps in the pathogenesis of stromal keratitis that are accessible to novel treatment procedures and will determine if combinations of drugs that target different steps of the disease process will be a superior approach for disease control.